Biostatistics

PROJECT SUMMARY (See instructions): The overall goal of the Biostatistics Core (Core B) is to promote scientific rigor in the conduct of RadCCORE research and to ensure the integrity of results. To this end, Core B will offer state-of-the-art biostatistics and bioinformatics support to RadCCORE projects and cores. This includes assistance in the statistical design, analysis and interpretation of data obtained from clinical, pre-clinical and laboratory studies, as well as molecular data obtained from genomic experiments and cell assays. Core B will also provide ongoing consulting and educational services to all RadCCORE investigators. Core B will use existing computing infrastructure resources as an efficient means to support RadCCORE research. It will also strive to take advantage of the vast amount of technical expertise in biostatistics, bioinformatics and information sciences within Duke University.

Public health relevance
Biostatistics plays an important role in biomedical research. Collaboration with biostatisticians has resulted in studies with clearly defined objectives, study designs well suited to address the questions being asked, and accurate and appropriate analyses. The Biostatistics Core (Core B) will provide the necessary biostatistics expertise and computational infrastructure in support of RadCCORE research.